Optogenetic dissection of Erk signal interpretation in early embryogenesis

PROJECT SUMMARY/ABSTRACT
Signaling pathways pattern cell fate choices in the developing embryo, but how do only a limited number of
pathways control the complex events of development? Spatial signaling gradients as well as temporal signaling
dynamics are known to be important for directing multiple fates with the same pathway, yet the mechanisms
cells use to interpret these signaling events remains largely uncharacterized. One pathway which plays diverse
roles throughout embryogenesis, wound healing, and cancer progression is the highly conserved extracellular
signal-regulated kinase (Erk) signaling network. The early Drosophila embryo is a classic in vivo model of
tissue patterning by Erk signaling: a spatial gradient of Erk signal at the poles specifies anterior and posterior
structure and dictates endoderm versus ectoderm fate decisions. Although these patterns are well-defined,
recent work in the Toettcher laboratory using an optogenetic tool to manipulate the Erk signal in vivo with
exquisite spatial and temporal precision has revealed major open questions about the mechanisms by which
Erk signals are interpreted. Here, I propose to define the mechanisms by which the Drosophila embryo
interprets differences in Erk dose to create spatial patterns of gene expression and make decisions about cell
fate. To address this question, I will use a combination of cutting-edge optogenetic tools, live-cell biosensors,
genomic analysis, and classical genetic perturbations. In Aim 1, I will examine how spatial patterns of gene
expression are robust to major corruption of the Erk gradient. In Aim 2, I will explore how only two transcription
factors can control multiple distinct fates over a wide range of Erk signal strength. Altogether, using precision
tools for manipulating signaling inputs and quantifying expression outputs, this proposal will reveal how Erk
signals are measured and interpreted by downstream genes, addressing a fundamental question in
developmental biology which will surely have relevance for other signaling pathways and cellular contexts for
Erk signaling. Through this research and the accompanying training plan I will obtain exceptional training in
optogenetics, advanced microscopy, and genomics, positioning me for an impactful career at the interface of
cell and developmental biology.

Public health relevance
PROJECT NARRATIVE The highly conserved extracellular signal-regulated kinase (Erk) pathway regulates tissue growth and patterning throughout development, and mutations in Erk pathway components are common causes of cancer. Understanding how cells interpret complex and dynamic Erk signals to yield distinct cell fates will significantly inform our understanding of how this pathway contributes to disease, yet these mechanisms have been difficult to identify. I propose to use innovative optogenetic tools in the Drosophila embryo, a classic and well-defined in vivo model for Erk signal interpretation, to define the molecular mechanisms by which this important pathway measures and interprets Erk signal dose to effect gene expression.